Data-driven control of primate prefrontal neural activity using patterned microstimulation

PROJECT SUMMARY
Artificially controlling neural activity in real-time is a central challenge in neuroscience and neuroengineering,
with significant implications for understanding brain function and developing treatments for neurological and
psychiatric disorders. Despite advances in high-precision neural perturbation technologies, a critical gap exists
in predicting and shaping the effects of these perturbations on neural population activity and behavior. Our
proposed research addresses this gap by developing a data-driven framework for real-time neural control,
integrating theoretical models, empirical analyses, and advanced stimulation techniques. Among circuit
perturbation methods, the effects of electrical stimulation remain particularly difficult to predict. However, this
technique is widely used in clinical treatments of neurological and psychiatric disorders, including Parkinson’s
disease, essential tremor, mood disorders, and obsessive-compulsive disorder. To maximize translational
impact and showcase the strengths of our theoretical framework, we focus on multi-electrode patterned
microstimulation sequences for circuit perturbations. In Aim 1, we investigate the spatial and temporal
summation rules governing multi-electrode microstimulation in monkey prefrontal cortex. By delivering
spatiotemporally patterned stimulation and measuring population responses, we aim to uncover the principles
of nonlinear summation and interaction effects, such as whether responses are stronger for spatially or
temporally proximal stimulations and for stimulation of high-impact “hub” electrodes. We also examine trial-to-
trial variability in stimulation responses as a function of network state, offering insights into how pre-existing
activity modulates stimulation effects. In Aim 2, we introduce a novel data-driven algorithm called Input/Output
Control (I/O-Ctrl) that predicts optimal stimulation patterns to evoke specific neural activity states. This
approach requires no prior knowledge of circuit dynamics or connectomes, instead relying on short training
sequences of stimulation-response data. By applying I/O-Ctrl to prefrontal circuits, we aim to develop a
generalizable framework for targeted neural modulation. In Aim 3, we extend these insights to behavioral
control, exploring how neural perturbations in prefrontal cortical circuits influence decision-making in primates.
Through closed-loop adaptive stimulation, we aim to identify neural mechanisms that bias choices and
examine the causal relationships between population activity patterns and behavior. The proposed work is
transformative, addressing key challenges in understanding and controlling neural circuits. By combining
computational modeling, multi-electrode stimulation methods, and real-time neural control frameworks, this
research has the potential to advance brain-computer interfaces, inform treatments for motor and cognitive
disorders, and uncover fundamental principles of brain function. These efforts will significantly enhance our
ability to manipulate and interpret neural circuits, with broad implications for neuroscience, medicine, and
artificial intelligence.

Public health relevance
PROJECT NARRATIVE Understanding how to control neural activity is crucial for developing treatments for brain disorders such as Parkinson’s disease, epilepsy, and depression. This research focuses on creating a new, data-driven approach for manipulating brain circuits using patterned electrical stimulation. By uncovering how stimulation influences brain activity and behavior, this work will improve therapeutic strategies and advance brain-computer interface technology, ultimately promoting better outcomes for individuals with neurological and cognitive impairments.